ORCASTRAIT Oregon Roybal Center for Care Support Translational Research Advantaged by Integrating Technology

Summary: Overall
This proposal takes advantage of the extensive expertise and infrastructure that has evolved from our Oregon
Roybal Center for Aging & Technology (ORCATECH) which developed a standardized framework for
conducting technology-related research in relevant populations, and a home-based platform to facilitate a wide
array of research use cases attuned to the older population. Thus, the Center has focused on creating
necessary research procedures, a unique Life Laboratory of community volunteers and researchers, basic
functional algorithms of human health-related activity and intervention outcome measures, and distinctive
collaborations to create new knowledge and facilitate knowledge exchange and dissemination. In this proposal,
we propose to build on this unique experience and infrastructure to create a new Roybal translational research
center, ORCASTRAIT (Oregon Roybal Center for CAre Support Translational Research Advantaged by
Integrating Technology). Adhering to NIH Stage Model principles. ORCASTRAIT is designed to facilitate the
wise use of technology to improve care provider support, affording the ready capacity to conduct (or
“orchestrate”) staged intervention research by providing a ready infrastructure to conduct necessary early
studies and to train and educate researchers in the optimal use and application of technology in their
interventions. Specific Aims are to:
1. Support a unique organizational infrastructure that enables and accelerates the process of developing,
translating and disseminating innovative care provider interventions facilitated by technology while fostering
cross-disciplinary and institutional collaborations and cooperation.
2. Advance timely, real-world development of care support intervention research through: a) A focused
ORCASTRAIT Life Laboratory network of AD-ADRD volunteers and care providers whose residences in the
community are enabled with pervasive computing capabilities dedicated for research; b) A Response via
Internet Technology and Experience (RITE) participatory research community and other related experience
sampling platforms informing user activities, attitudes and beliefs; and c) Shared Data Resources.
3. Provide structured, but flexible educational opportunities to advance the research workforce attuned to
integrating technology in dementia care intervention research. This will incorporate the TIPS (Technologies
for Intervention Practicum and Study) program, as well as the online Technology Research and Care
Support (TRACS) study modules.

Public health relevance
Narrative: Overall ORCASTRAIT is dedicated to developing effective care support interventions facilitated by wise use of technologies that optimize health and quality of life for people with dementia and their care providers. Such technologies hold tremendous promise as public health systems strive to identify innovative and more effective ways to help the growing population affected by Alzheimer’s and related disorders.